Project 4: Epigenetic Regulation of Retrotransposons in the Mouse and Human Germline

Project Summary
Germ cells undergo extensive epigenetic reprogramming during development. During this critical period,
retrotransposons are reactivated due to genome-­wide erasure of DNA methylation and are re-­silenced by de
novo DNA methylation. Retrotransposons, mainly LINEs, SINEs, and endogenous retroviruses (collectively
referred to as junk DNA), occupy 40% of the mammalian genome. Although retrotransposons play an
important role in genome evolution, their mobilization could be detrimental to genome integrity. Multiple
epigenetic mechanisms are responsible for silencing retrotransposons in the germline: DNA methylation,
repressive histone modification, small RNAs, and heterochromatinization. Given the extreme abundance of the
retrotransposons and the paramount importance of germline genome integrity, novel mechanisms for
retrotransposon silencing may exist. In support, we have found that TEX15, a germ cell-­specific 3059-­aa
protein with a newly identified functional domain, is required for meiosis and male fertility, and is a novel
epigenetic regulator essential for retrotransposon silencing. Based on these data, we hypothesize that TEX15
is a novel germ cell-­specific regulator of retrotransposon activation and that meiotic collapse is the
ultimate “fail-­safe” mechanism for preventing transmission of male germ cells in which
retrotransposons are inordinately activated. In this project, we will 1) determine the TEX15-­mediated
epigenetic landscape during male germ cell development in mouse using genomic approaches, 2) elucidate
molecular mechanisms underlying TEX15 function, and 3) screen for retrotransposon activation and utilize
whole exome sequencing to identify genetic mutations that compromise epigenetic silencing of
retrotransposons in testis biopsies from azoospermic men. Together, these studies will identify novel factors in
the silencing of retrotransposons and provide essential insights into the etiology of male infertility in humans.